SLEEP APNEA AS A NEUROEXCITATORY STATE

Repetitive apneas during sleep result in sleep fragmentation and intermittent hypoxemia. Both of these events could result in increased catecholamine excretion or production, hormonal stress responses (cortisol, ACTH, DHEAS), and/or sympathetic neural excitation. Patients are studied before and after therapy for sleep apnea with severe disease.